Investigating the Pathogenic Role of Tubulin Post-translational Modifications in CIPN

SUMMARY
Chemotherapy induced peripheral neuropathy (CIPN) is the most prevalent neurological complication of
oral or intravenous chemotherapy. Approximately 50–90% of patients under chemotherapy are affected by CIPN
and bear a high risk of chronicity (approx. 30–40%). Limited symptomatic relief is provided by opioid analgesics,
antidepressants, or anticonvulsants. Unfortunately, the pathogenesis of CIPN is still largely unknown. Several
different classes of anticancer drugs acting through different antineoplastic mechanisms can induce CIPN.
However, sensory impairment is always either the only or predominant adverse effect, suggesting the existence
of a common mechanism of pathogenesis.
Tubulin is the building block of microtubules and a well-established target for multiple anticancer drugs
that can promote CIPN. The contribution of tubulin changes to the onset of CIPN is not well understood but is
strongly implicated as the determining factor. Tubulin and microtubules play crucial roles in sensory neuronal
functions including the distribution of cargos to distal regions of the nerve, TRP channel activity and regulation
of mitochondrial dynamics.
The overall hypothesis of this proposal is that CIPN-promoting drugs may share an underlying
mechanism of pathogenesis based on modulation of tubulin post-translational modifications at a prodromal stage
of the disease. We will further evaluate whether accumulation of delta-2 tubulin, an irreversible modification of
a-tubulin, which we recently found to mediate axonal degeneration by the anti-cancer drug bortezomib, plays a
common pathogenic role in the neuropathic damage inflicted by unrelated CIPN-promoting drugs. Finally, we
will examine the contribution of mitochondrial and TRP channel dysfunction in the axonopathy induced by
accumulation of D2 in DRG neurons.
Our proposal is based on our published data and the development of robust cellular and preclinical
models of CIPN generated by an ongoing collaboration between the PI and Dr. Yalda Moayedi, a co-investigator
on this application. Collectively, our studies will provide mechanistic insights into a unifying model of
pathogenesis for the development of CIPN based on tubulin modifications and will directly examine the
unexplored potential for tubulin-modifying enzymes in drug therapies aimed at preventing axonal injury and
neuropathic pain in CIPN. They will also pave the way to analyze the pathogenic role of modified tubulin in the
onset of other chemotherapy-related adverse sequelae such as nephrotoxicity or ototoxicity as well as idiopathic
or inherited forms of peripheral neuropathy in addition to CIPN.

Public health relevance
NARRATIVE Our proposal relies on a multidisciplinary effort between researchers with complementary expertise to investigate the pathogenic potential for tubulin post-translational modifications (PTMs) in the onset of chemotherapy induced peripheral neuropathy (CIPN) and the mechanisms of CIPN-related drug dependent induction of tubulin and microtubule injury. In the short-term, our studies will examine a novel unifying theory of pathogenesis based on alteration of tubulin PTMs and determine the role for delta-2 tubulin in the onset of neuropathic damage induced by CIPN-promoting drugs by interfering with mitochondrial and TRP channel function. In the long-term, this work has the potential to reveal tubulin perturbation as the driver of axonal dysfunction caused by chemotherapeutics and to identify novel targets that may be modulated in drug therapies aimed at rescuing other chemotherapy- related adverse sequelae such as nephrotoxicity or ototoxicity as well as idiopathic or inherited forms of peripheral neuropathy in addition to CIPN.